Advanced Technology Core

ADVANCED TECHNOLOGY CORE (CORE C)
PROJECT SUMMARY
Leveraging the collective scientific expertise and resources across the DC CFAR partner institutions, the
Advanced Technology Core (ATC) will provide an array of high impact laboratory services and training to HIV
investigators in Washington, DC. Under the leadership of NIH-funded senior scientists and with a cadre of DC
CFAR-supported Core service providers, the ATC will actively support high priority advanced technology
services in virology, immunology, proteomics and bioinformatics, and provide access to other key laboratory
services that utilize advanced technologies including single-cell analysis, -omics, specialized immunologic
assays, CRISPR technologies, complex imaging, cryo-electron microscopy, machine learning, and HIV
reservoir assays. The ATC will assist investigators in acquiring preliminary data for grant applications; conduct
funded research protocols; and foster linkages with the Scientific Working Groups (SWGs) and Scientific
Interest Groups (SIGs) and clinical and translational investigators. For Specific Aim 1, the ATC will provide high
impact and advanced technology laboratory services (including single-cell analysis, omics, specialized
immunology, CRISPR technologies, complex imaging, cryo-electron microscopy, machine learning, and HIV
reservoir assays) to DC CFAR investigators. For Specific Aim 2, the ATC will facilitate service dissemination
and training in advanced techniques and assays to recipients of Pilot, Transitioning Investigator, and NIH
awards by organizing DC CFAR institutional workshops, the Core service laboratory “open house” series, and
the annual Core Service Providers Research Day. For Specific Aim 3, the ATC will promote multidisciplinary
forums by organizing workshops and seminars with the goal of connecting social, behavioral, clinical, and
population scientists with the basic science investigators who are utilizing advanced technologies. These
activities will contribute to addressing the DC CFAR mission of ending the HIV epidemic in Washington, DC
and improving the health and quality of life of persons with HIV.